Finding the Ethical Path Forward: A Bioethical and Stakeholder-driven Investigation on the Sharing of Palliative-related Survey Results with Patients, Caregivers and Community Clinicians

PROJECT SUMMARY/ABSTRACT
Despite growing advocacy to make health data available to patients a standard in clinical care, clinical
research data are often not shared with participants despite the potential for this data to improve care and real-
world outcomes. The literature shows that most participants want to receive research results. However, there is
no clear guidance or consensus on how to ethically and effectively return individual non-genetic research
results (IRR). Notably, efforts for increasing transparency in clinical research have been largely limited to
genomics with few studies looking at the much more common, and potentially actionable, patient reported
outcomes (PRO) collected in the course of clinical research. In this supplement, we focus on return of these
patient-reported outcomes to patients, family carepartners, and community clinicians from the perspectives of
these key stakeholders, as well as researchers and bioethics. The proposed project is a one-year Bioethics
Supplement that leverages an ongoing R01-funded pragmatic trial of community-based palliative care for
people living with Parkinson's disease (PD) and Lewy Body Dementia (an NIH-designated Alzheimer Disease
Related Disorder; ADRD). Stakeholder participants for this supplement will include our community clinician
partners, as well as patients and family carepartners who have completed their final data collection for the
parent trial. By making available PROs, it is possible that researchers may increase engagement of
participants, convey respect for participants' autonomy, and empower participants' personal decision-making
processes. There are also risks, such as increasing anxiety or distress, providing information that is not
actionable, interfering in the patient's relationship with their community provider, and contaminating research
results if this information leads to changes in health behaviors. There are also privacy concerns regarding what
information is shared between patients and family carepartners and between the clinician and the carepartner.
It is thus critical to understand what, when, and how to share IRRs. The Specific Aims of this supplement are
to: 1) Elicit input from key stakeholders (patients, caregivers, community clinicians, and investigators) to
understand views, concerns, and preferences on returning patient- and caregiver-reported outcomes using
mixed methods; and, 2) Engage an interdisciplinary committee of bioethicists, palliative care researchers,
community clinicians, carepartners, and individuals with PD in a review of the key findings to develop
preliminary recommendations about the return of PROs. Lessons learned through this research will inform our
future work in PD and palliative care research, including building capacity to incorporate returning patient
reported outcome (PRO) results to participants in an ethically sound manner. We anticipate this work will have
implications for clinical research outside of palliative care and neurology and may set a foundation for future
studies looking to ethically integrate return of PROs and other non-genomic IRRs into trial design.

Public health relevance
PROJECT NARRATIVE Despite growing advocacy to make health data transparent and available to patients and family in clinical care, data in research clinical trials are often not shared with research participants, even though there is the potential for these data to improve their care and real-world outcomes. In this Bioethics Supplement to our parent trial of community-based palliative care for persons living with Parkinson's disease, we will investigate the concerns and preferences of key stakeholders (patients, family carepartners, community clinicians, and researchers) regarding the return of patient- and caregiver-reported outcomes and engage an interdisciplinary committee of bioethicists, palliative care researchers, research participants, and community clinicians to review key findings and develop preliminary recommendations about the return of individual research results. Lessons learned through this research will have implications for future research studies and provide guidance on whether and how to incorporate returning patient-reported outcome results to participants.